Executive function and impulsivity as predictors of alcohol/cannabis co-use in adolescence: a longitudinal study

The overall goal of this K01 proposal is to examine cognitive, behavioral, and brain-based markers of self-
regulation as predictors of cannabis and alcohol co-use in adolescence. Between 2-6% of early adolescents
aged 13-14 years report cannabis and alcohol co-use, and co-use is associated with more adverse outcomes
(e.g., engaging in high-risk behaviors) compared to single-drug use. Problems with self-regulation have been
linked to alcohol and cannabis use individually, but less is known about self-regulatory vulnerabilities in the
context of future adolescent cannabis and alcohol co-use. To address this gap, Dr. Goncalves proposes to study
two drivers of reduced self-regulation: lower executive functioning, and high impulsivity, prior to the onset of
alcohol and substance use in two extensive population studies (1- Collaborative Study on the Genetics of
Alcoholism [COGA], 2- the Adolescent Brain Cognitive Development [ABCD]) and through collecting pilot data
using an ongoing multigeneration family study (MFS). This proposal will evaluate self-regulation markers (using
cognitive tasks, behavioral scales, and structural neuroimaging measures) prior to the onset of use in late
childhood and adolescence. Aim 1 will investigate this question using the COGA study, in which self-regulation
was assessed at ages 12-16, cannabis and alcohol use at ages 16-20, and cannabis/alcohol use disorders at
ages 20-24. Aim 2 will test this question in the ABCD study, where self-regulation (i.e., cognitive tasks and
cortical thickness) was assessed at ages 9-10 years, and cannabis and alcohol use and co-use starting at ages
13-14 years. Aim 3 will test this question in MFS, where self-regulation was previously assessed at ages 6-12
years, and Dr Goncalves will collect data on use, co-use and risk perception associated with cannabis and
alcohol co-use at 12-18 years. This multi-study proposal will allow testing of how impairments in self-regulation
and abnormalities in frontal cortical thickness (prior to any substance use) are associated with future cannabis
and alcohol use and co-use and their associated disorders. These results will inform an R01 application, focusing
on examining risk and resilience factors for cannabis and alcohol co-use and co-occurring cannabis and alcohol
use disorders when the ABCD participants are ages 17-18. Finally, findings of the proposed K01 project will
inform the development of an R21 application focused on a pilot intervention for polysubstance in adolescents.
In addition to answering the above research questions, this project will serve as a training vehicle for Dr.
Goncalves, providing her advanced training in self-regulation development, frontal cortical thickness
development in late childhood and adolescence, and development and operationalization of pilot data collection
on an adolescent sample. The training plan builds on the candidate's prior clinical experience, and capitalizes
on a stellar mentorship team and research environment to foster Dr. Goncalves' development. This K01 proposal
will fulfill Dr. Goncalves' training needs, enable her transition to being an independent Latina researcher, and
ensure that she becomes a leading expert in adolescent neurocognitive development and polysubstance use.

Public health relevance
Project Narrative This project aims to investigate cognitive and neurobiological mechanisms as predictors of a risky pattern of poly-substance use, cannabis and alcohol co-use, at different stages of adolescence using two large population studies (COGA, ABCD) and through collecting pilot data on use and co-use in a multigeneration family study (MFS). Using behavioral and neuroimaging measures, I will investigate self-regulation prior to substance initiation to understand executive functioning and impulsivity mechanisms related to future cannabis and alcohol co-use and cannabis/alcohol use disorders during adolescence. Having a broader understanding of self- regulation mechanisms will contribute to identifying at-risk children and adolescents before substance initiation, which can have immense clinical, prevention, and public health implications.